Molecular and immune drivers of immunotherapy responsiveness in prostate cancer

PROJECT SUMMARY
Despite recent advances in treatment, metastatic castration resistant prostate cancer (mCRPC) remains
incurable, and approximately 30,000 men die of this disease yearly. Advances in immunotherapy with drugs
targeting immune checkpoints have raised hopes that these agents will improve outcomes for mCRPC
patients. While initial studies of immune checkpoint blockade have been unsuccessful, emerging evidence
suggests a subset of prostate cancer (PCa) patients can respond, although the mechanisms of PCa
immunotherapy response and resistance are incompletely characterized. Work in other immunotherapy
responsive malignancies has found several predictive immune and tumor-intrinsic properties that contribute to
response, but the extent to which these (or other) features are operant in PCa is largely unknown. For
example, we recently identified mutations in a chromatin remodeling complex that mediates immunotherapy
response through T cell interactions in solid tumors, and in parallel discovered a previously unknown PCa
genomic subclass defined by mutations in these same chromatin remodelers. These findings indicate that
tumor-intrinsic epigenetic dysregulation may also interact with the immune system to modulate PCa
immunotherapy responsiveness. The overarching hypothesis of this project is that multiple immune and tumor-
intrinsic properties mediate PCa interactions with the immune system, and these interactions can be modified
through selective targeting in combination with checkpoint blockade to expand the therapeutic potential of
immunotherapy in PCa. We will leverage our team's deep experience in clinically grounded molecular
characterization and preclinical models that can test immunotherapy combinations in PCa to define the
processes that govern the immunotherapy landscape in PCa. The proposed specific aims are: 1) Define the
systemic and infiltrating immune states in PCa associated with clinical response to checkpoint blockade; 2)
Establish the immunologic impact of chromatin dysregulation and inhibition in PCa; and 3) Determine the
impact of existing DNA damaging agents for sensitizing PCa to PD-1 blockade. This proposal leverages the
extensive, novel, and complementary resources at both Dana-Farber/Broad Institute and University of
California, San Francisco, led by highly collaborative investigators and an international scientific team, to
address the hypotheses outlined herein. Through a combination of functional, molecular, and clinical
approaches inherent in these studies, our team is poised to identify mCRPC cohorts that may benefit from this
treatment paradigm, determine strategies to augment the use of checkpoint inhibitors in this disease, and
mechanistically define the immune and tumor-intrinsic defects that drive immunoresistance in PCa. Broadly,
this project will provide a unique approach for the Immuno-Oncology Translation Network (IOTN) community
and enable discovery of anti-cancer immunotherapies strategies for PCa that may have larger relevance
across the IOTN network and collaborating members of the Cancer Immunotherapy Consortium.

Public health relevance
PROJECT NARRATIVE While immunotherapy has transformed treatment for numerous malignancies, this benefit has not been fully realized in prostate cancer. To overcome this critical challenge, we have created a multidisciplinary and highly collaborative program to define immune cell composition, states, and interactions that mediate selective immunotherapy response; prove that specific tumor-intrinsic somatic mutations in chromatin regulators drive immunotherapeutic responses in a heterogeneous prostate cancer population; and identify combination treatment strategies to boost responses in aPD-1 non-responsive PCa. Overall, this program will conduct systematic how promote and comprehensive investigations of tumor cells evade the immune system, and anti-tumor immune responses. host immune cell-prostate cancer cell interactions to define identify strategies to reprogram immune and tumor cells to